Targeted interventions to reduce or eliminate the SIV reservoir in a novel model of elite control

Project Summary
HIV-1 infection is typically well controlled with combination antiretroviral therapy (ART). However, viral
reservoirs persist in lymphoid tissues leading to rapid rebound viremia following ART discontinuation. The
mechanisms that underlie viral persistence include latency, proliferation or clonal outgrowth of cells harboring
intact viral genomes, and immune responses that are inadequate to access or kill infected cells. After almost a
decade of intensive research to cure HIV infection, there has been little success in eliminating or even reducing
HIV-1 reservoirs, indicating that barriers to achieving this goal are formidable. It has become clear that basic
questions and mechanisms of how viral persistence is maintained need to be addressed in relevant animal
models that can reveal vulnerabilities in these reservoirs and inform hypothesis-driven interventions to impact
their size and durability. The Hoxie lab has described a unique nonhuman primate model in which a 2 amino
acid deletion in the SIVmac239 envelope cytoplasmic tail, disrupting a highly conserved cellular trafficking
signal, produces a virus termed ∆GY that is highly replication fit during acute infection but is rapidly controlled
to undetectable levels in plasma by cellular immune responses in the absence of neutralizing antibodies. Viral
reservoirs are clearly present years after infection, as demonstrated by anti-CD8 cell depletion studies, and
have been detected and quantified by state of the art assays in PBMCs and lymphoid tissue. This proposal will
use the ∆GY model of elite cellular control to test the hypothesis that an intervention with a potent and long-
lasting neutralizing antibody, with or without the latency reversing-like activity of CD8 cell depletion, thus
exerting both cellular and humoral immune attack on the viral reservoir, will accelerate the decay of and/or
eliminate replication competent viruses. Four Specific Aims are proposed: 1) to define and quantify viral
reservoirs during elite immunologic control of ∆GY, characterizing relevant cell types, transcriptional activity,
integration sites, and mechanisms that underlie persistence; 2) determine if long term expression of eCD4-Ig, a
novel engineered antibody-like molecule with potent neutralizing and non-neutralizing functions against
SIVmac239 and ∆GY, with or without CD8 cell depletion to activate virus production, can synergize with host
cellular immune responses to reduce reservoirs; 3) extend findings from Aims 1 and 2 to SIVmac239 infection
in which viral control prior to eCD4-Ig and CD8 cell depletion is exerted through ART rather than cellular
immune control; and 4) create novel SHIV and HIV-1 isolates that contain mutations analogous to the ∆GY
mutation for future studies to explore interventions that can build on the findings of this proposal to reduce or
eliminate persisting HIV-1 reservoirs. If viral reservoirs in the ∆GY model can be reduced or eliminated, this
study will provide a proof of concept that this goal is feasible, and inform immunological interventions during
ART-suppression animal models and in humans.

Public health relevance
Project Relevance HIV-1 establishes reservoirs that resist drug and immunological treatments, indicating that basic studies are needed to understand how to target these sites. We have described an SIV model in which a mutation in the envelope cytoplasmic tail leads to cellular immune control but with persistent reservoirs. Our proposal takes advantage of unique attributes of this model to assess novel interventions that can reveal vulnerabilities in the reservoir and inform targeted approaches to eliminate HIV-1 reservoirs in humans.